Targeting Surfactant Protein A to Prevent Retinopathy of Prematurity

PROJECT SUMMARY
Retinopathy of prematurity (ROP) is a potentially blinding vaso-proliferative disease frequently seen in
prematurely born infants with lifelong consequences for both the infant and society. The c-type lectin,
Surfactant Protein A (SP-A), is an immunomodulatory protein, found to be deficient in prematurely born infants.
Lack of SP-A is associated with lung disease of prematurity and a temporal association with pulmonary
vascular growth factors has been previously reported. We previously discovered that SP-A is expressed in the
Müller retina and plays an important role in neovascular disease (NV) with a pro-angiogenic phenotype. Our
preliminary data now shows SP-A promotes early retinal vascular development, and conversely, lack of SP-A
is seen in response to hyperoxia in rodent models. SP-A has a positive association with expression of retinal
vascular endothelial growth factor (VEGF), cytoskeleton proteins and associated chaperones necessary for
both cytoskeleton and VEGF folding. Our results suggest that deficiency of SP-A leads to reduced vascular
growth in endothelial cells both in the rodent retina and in vitro impacting retinal angiogenesis. Conversely, in
the second stage, SP-A acts in a proangiogenic fashion to drive NV. Given that current anti-VEGF therapies for
ROP may result in delayed re-appearance of NV and may also depress systemic VEGF levels with
consequences for the growing preterm infant, there is a critical need to develop safe and targeted therapies for
ROP and most importantly- to prevent it. We hypothesize that the SP-A protein and associated pathways
represent novel therapeutic targets to rescue early hyperoxia and prematurity related vascular arrest. It is
imperative to understand the mechanisms for these complex cell-intrinsic properties. In this proposal we will
examine cytoskeleton, chaperone and S-A receptor molecules using transgenic strains with targeted deletion
of SP-A and Myo18A receptor in Müller and endothelial cells. We will examine the association between SP-A
and the chaperone aCrystallinB which drive post-translational modification of cytoskeleton and vascular growth
factors. The goals of this proposal are to characterize the SP-A/chaperone/VEGF axis, to confirm Myo18A as
the SP-A receptor and study the impact of SP-A on endothelial cell cytoskeleton and endothelial cell function.
Finally, we will test the therapeutic potential of targeting SP-A protein in early disease in a rodent ROP model.
These goals have clear

Public health relevance
PROJECT NARRATIVE Surfactant Protein A (SP-A), is an immunomodulatory protein associated with lung disease of prematurity, abnormal vascular growth, and with Retinopathy of Prematurity (ROP); the leading cause of acquired childhood blindness worldwide. However, the mechanisms by which it drives blood vessel growth are unknown. Understanding the function of this protein in normal and pathological contexts is critical to developing novel, rational and safe therapies for preventing and curing neovascular eye diseases.